Transforming Care Delivery Models for at-Risk Young Adult Patients with Congenital Heart Disease and Amplifying Research Efforts to Improve Health Equity in Pediatric Chronic Disease Care

PROJECT SUMMARY/ABSTRACT
Advances in pediatric subspecialty care have improved the health of children who previously died, but now are
reaching adulthood, creating a fast-growing population of survivors. One example is congenital heart disease
(CHD), the most common birth defect, where now more adults with CHD are living than children. Disparities in
subspecialty health outcomes are magnified throughout the lifespan, in part due to failures in transitioning from
pediatric to adult providers, and in part due to a dearth of adult providers who understand pediatric chronic
conditions. Less than 10% of adults with CHD receive appropriate CHD care, with few adult cardiologists
trained to manage long-term CHD issues. Furthermore, scarcity of adult CHD (ACHD) providers makes it
especially challenging to access ACHD physicians, particularly for racial and ethnic minorities and those from
lower socioeconomic status (SES) and rural environments. Thus, a critical need exists to increase pediatric
health equity researchers to recognize and address subspecialty health disparities throughout the lifespan. In
this innovative grant, we propose utilizing existing expertise and infrastructure to train a new generation of
pediatric health equity researchers caring for high-risk chronic disease populations through a REsearch And
Career Health Equity System (REACHES). This system merges experts from Baylor College of Medicine
Population Sciences-Shared Research CORE and Texas Children's Hospital Health Policy Center to support
trainees and pediatricians whose research, advocacy or QI projects focus on health equity. REACHES directly
addresses two NIH NIMHD objectives: 1) to foster innovative collaborations and partnerships, and 2) support
the training of a diverse research workforce. Our proposed research exemplifies our REACHES expertise by
leveraging existing collaborative relationships and infrastructure with the TX Birth Defects Registry (TBDR), TX
A&M Department of Public Service and Administration (PSAA), Geographic Information System (GIS) mapping
experts, and the Adult Congenital Heart Association (ACHA) to address health disparities in transitioning ACHD
(18-24 yo) patients with moderate to severe CHD in Texas. We plan to 1) identify young ACHD with high-risk
sociodemographics (low SES, rural, and minoritized patients) for gaps in care 2) investigate key barriers to
ACHD care for patients 3) use barrier data to inform an ACHA patient navigation intervention to increase
access to ACHD care, and 4) transform the delivery of ACHD care through operationalizing an adapted hub-
and-spoke medical home model for CHD care (MMCC), comprised of an adult cardiologist at the hub with
pediatric and ACHD subspecialty consultation, and determine acceptability of the MMCC strategy to deliver
remote ACHD care using telemedicine and Project ECHO (a platform facilitating access to specialty expert
management and learning). This research directly addresses two NIH NIMHD objectives: 1) plan and
coordinate research in health disparities, and 2) address the multi-faceted nature of health disparities. Our
long-term goal is to increase pediatric health equity researchers and deliver equitable pediatric lifespan care.

Public health relevance
PROJECT NARRATIVE Adult survivors of CHD are the fastest growing group of CHD patients, approximating 40,000 per year, and with more adults now living with CHD than children; yet obstacles to transitioning from pediatric to adult care puts them at risk for significant morbidity and mortality. In this proposal, we aim to reduce care disparities in young adults with CHD by: 1) understanding geographic access and use of patient navigation to adult CHD services for high-risk populations (rural, minority and low socioeconomic status), 2) identifying barriers for transitioning successfully from pediatric to adult-oriented cardiac health services and partnering with adult CHD experts to actively re-engage high-risk patients in appropriate ACHD care, and 3) exploring novel medical shared care delivery models to increase the adult CHD workforce and improve long-term morbidity and mortality for this rapidly expanding population. We also propose to create the infrastructure for a novel REsearch And Career Health Equity System (REACHES) program to train a new generation of pediatric health disparities researchers.